Study of Aging Latinas/os for Understanding Dementia in HIV (SALUD HIV)

HIV remains a major public health problem, particularly for the Latina/o population. US-dwelling Latinas/os are
at increased risk for HIV-infection compared to non-Hispanic whites and suffer a disproportionate burden of
HIV-associated neurocognitive disorder (HAND) which may be amplified with age. HIV-infected (HIV+)
Latinas/os of Puerto Rican origin have the highest prevalence of HAND (~78%) of any group in the US (HIV+
Mexican Americans: 44%; African Americans: ~40%, & non-Hispanic whites: ~40%). Older HIV+ Latinas/os
(50± years) appear to be at even greater risk for HAND and cognitive decline than their non-Hispanic white
counterparts, and the pattern of cognitive impairment in HAND appears to differ by ethnicity. In the general HIV
population, HAND is characterized by impairments in processing speed, attention, and executive functioning
consistent with involvement of the frontostriatal circuitry. HIV+ Puerto Rican Latinas/os present an atypical
amnestic memory profile more consistent with medial temporal lobe (MTL) involvement. Despite these
important disparities, differing cognitive profiles and possible differences in affected neural structures, the
literature on HAND in Latinas/os is almost entirely cross-sectional, does not include HIV-uninfected (HIV-)
controls, lacks studies focused on brain integrity in this population, and has yet to examine the mechanisms
underlying these disparities. Utilizing a culturally-tailored approach, the goals of this study are to investigate
whether older HIV+ Latinas/os of Puerto Rican origin demonstrate worse patterns of decline in cognitive
function and brain integrity compared to other ethnic/HIV status groups, and to uncover the biological (e.g.,
neuroinflammatory biomarkers [sTREM2, sCD14, sTNFR-II, & IL-6], cardiovascular burden) and sociocultural
(e.g., acculturation, social adversity, stress) mechanisms conferring risk for neurodegenerative and cognitive
changes in this population. To that end, this multidisciplinary study will deploy a longitudinal observational
design with 90 HIV+ and 90 HIV-matched control adults (both groups will include: 70% Latina/o and 30% non-
Hispanic white; aged 60-80 yrs) over 36-months. All participants will complete laboratory, neuromedical,
multimodal neuroimaging, and comprehensive cognitive and sociocultural assessments. Longitudinal structural
equation models will test relationships between ethnicity, HIV, and biological and sociocultural factors on
cognition (global, learning, memory, & processing speed) and MRI brain indices (white matter lesion & MTL
gray matter volumes; MTL intrinsic activity, & hippocampal intra-network connectivity). Addressing disparities in
cognitive and brain health outcomes in Latinas/os offers a vital opportunity to elucidate HAND
neuropathogenesis, disentangle the biological and sociocultural aspects of cognitive aging through the lens of
HIV-infection, and identify modifiable factors to mitigate risk for cognitive decline. As this population is the
fastest-growing sector of the US aging population, identifying culturally-relevant intervention targets to lower
age-related cognitive morbidity in Latinas/os is key for promoting brain health equity and public health.

Public health relevance
PROJECT NARRATIVE HIV remains a major public health problem, particularly for the US Latina/o population who is at increased risk for HIV-infection compared to non-Hispanic whites, and suffer a disproportionate burden of HIV-associated neurocognitive disorder (HAND), which may be amplified with age. Utilizing a biopsychosociocultural theoretical framework, the proposed multidisciplinary study will investigate whether older HIV+ Latinas/os of Puerto Rican origin demonstrate greater declines in cognition and brain integrity compared to other ethnic/HIV status groups, and to examine the biological (e.g., neuroinflammatory biomarkers [sTREM2, sCD14, sTNFR-II, & IL-6] and cardiovascular burden) and sociocultural (e.g., acculturation, social adversity, stress) mechanisms increasing risk for neurodegenerative and cognitive changes in this population. Addressing dementia and HAND health disparities in Latinas/os is vital for public health to: 1) improve our understanding of biological and sociocultural aspects of neurosenescence and cognitive aging through the lens of HIV infection; 2) advance dementia research in other conditions (e.g., Alzheimer’s Disease [AD] & related dementias [ADRDs]) by offering greater understanding of sociocultural variations in the neuropathogenesis of dementia; 3) inform culturally-relevant and targeted interventions that could lead to better Latina/o cognitive and health outcomes in HIV and other chronic conditions that disproportionately burden this population (e.g., AD, ADRDs); and 4) provide a framework for studying and addressing dementia and HAND in Latin American countries that also bear a heavy HIV burden.